Community Engagement and Dissemination Core

ABSRACT – COMMUNITY ENGAGMENT AND DISSEMINATION CORE
The overarching goal of the Community Engagement and Dissemination (CoED) Core is to build
community research capacity to address health disparities and inequalities to create a foundation for health
equity among Community-Based Organizations (CBOs) and academic partners. Further, this core is charged
with delivering findings via community-relevant messages in English and/or Spanish as well as to the scientific
community. Foundational theories for partnership activities include using the NIMHD Research Framework,
Social Determinants of Health, and Syndemics to understand the scope of health disparities to create health
equities in our U.S.-Mexico border community. Initial activities include establishing key priorities for the five-
year project. The CoED Core focuses on knowledge and skills development for the community-investigator
partnerships through the Pilot Project Program (PPP) and Community Engaged Mentorship (CEM) in the
Investigator Development Core for understanding and conducting ethical, mutually beneficial, culturally
appropriate, and meaningful community-based participatory research. The Core will use the Community
Academic Partnership for Health Sciences Research (CAPHSR)'s Guiding Principles and Research
Expectations for the PPP and community investigators. Additional activities target the skills to deliver health
messages in a culturally and linguistically inclusive manner (English and Spanish) to reach U.S.- Mexico
border constituents. The Core will use a Dissemination Planning Matrix to identify relevant strategies and
media for communicating health disparities and ultimately research findings to the Community Based
Organization (CBO) stakeholders and to the community at large. The PPP teams will provide annual writing
workshops to engage and integrate the community voices when writing for a scientific audience. To further
community integration, online writing groups will be implemented to involve community members in the co-
creation of the writing process. This multi-layered approach to engaging community voices in translational
research and dissemination will result in an increased capacity to identify, evaluate, address, and communicate
health disparities findings to the U.S.- Mexico border community. Our center builds on a strong foundation of
demonstrated commitment for the unique diversity of our bilingual, binational, multicultural communities,
trajectory of effective community-engaged scholarship and partnerships, a solid record of intellectual capacity
and robust support from community-based organizations. The CoED team with demonstrated community
engaged scholarship will support the goals of the Investigator Development core and the center as a whole to
advance community engaged transdisciplinary Hispanic health disparities research. Our ability to identify and
develop community engagement and dissemination opportunities will leverage our strengths and continue to
adapt and propel health equity.